Mechanisms of barrier dysfunction and tissue hyperplasia in CRS

The Chronic Rhinosinusitis Integrative Studies Program 2 (CRISP2) is an integrated program of epidemiologists,
otolaryngologists, allergists and immunologists in which highly collaborative studies are proposed to better
understand the molecular and cellular mechanisms of disease heterogeneity and how these mechanisms
translate into clinical phenotypes, natural history and long term outcomes. The program focuses on CRS without
nasal polyps (CRSsNP), a highly prevalent and yet obscure phenotype from the standpoint of current
understanding. Another focus of CRISP2 is to critically evaluate the mechanisms and consequences of comorbid
conditions in which patients have both CRS and lung disease such as asthma or bronchiectasis. To achieve
these goals, the investigators on the CRISP2 study team have innovated new assays and approaches to cutting
edge studies of pathogenesis and epidemiology and, most importantly, have merged these two disciplines to
relate mechanisms to symptoms, severity, history and outcomes of CRS. Epithelial barrier dysfunction, induced
by injury and inflammation, can lead to barrier loss, which activates epithelial-mesenchymal transition (EMT)
during the epithelial repair process. Project 1 investigates the mechanisms of barrier dysfunction and its role in
CRS severity and outcomes. Another topic follows our findings that tissue hyperplasia is driven by deposition of
cross-linked fibrin. Linking barrier loss and fibrin deposition are preliminary data suggesting that both EMT and
fibrin deposition are driven by type 2 inflammation. Project 1 will be the first to study mechanisms of hyperplastic
changes confined to the sinuses in a newly defined phenotype of CRS (CRSsNP-HP). Barrier dysfunction and
fibrin deposition will be related to immunological endotype and their influence on phenotype, comorbidity and
outcomes assessed. Studies in aim one test the hypothesis that loss of barrier integrity and function is induced
by oncostatin M (OSM), thyroid hormone and epiregulin (EREG), and associates with type 2 inflammation.
Epithelial EMT will be monitored with a novel microparticle-based assay applicable to large numbers of nasal
lavage fluids from patient cohorts at NU (tertiary care) and Geisinger (primary care). Single cell RNA-Seq studies
will evaluate epithelial differentiation and EMT in samples from patients with CRS. The second aim tests the
hypothesis that type 2 inflammation promotes fibrin deposition and formation of hyperplastic tissue, based on
results implicating loss of fibrinolytic pathways and increased levels of fibrogenic mediators. We predict that
biochemical measurement of tissue fibrin will correlate with endotype and hyperplastic tissue changes (polyps >
hyperplastic disease >> non-polypoid disease) and will monitor the coagulation system, fibrinolysis and fibrin
deposition in patients with defined endotypes to test this hypothesis. The third aim tests the hypothesis that
autoimmune antiphospholipid antibodies promote fibrin deposition in CRS. We have detected autoantibodies in
nasal polyp tissues, including procoagulant anti-phospholipid antibodies (APA) antibodies. We will evaluate APA
specificity and the relationship between APA antibodies and fibrin deposition in CRSwNP and CRSsNP-HP.